Advanced Dual-Nuclei MRI for Differentiation of Recurrent Brain Metastases and Radiation Necrosis

PROJECT SUMMARY
Brain metastases (BM) are the most common intracranial tumors in adults, affecting 10–40% of cancer patients.
Stereotactic radiosurgery (SRS) is a standard treatment for BM, but assessing treatment response is challenging
due to the difficulty in distinguishing recurrent brain metastasis (rBM) from radiation-induced necrosis (RN) using
conventional imaging methods. Both conditions can appear similar on conventional magnetic resonance imaging
(MRI) but require markedly different management strategies: rBM may necessitate aggressive interventions,
while RN is often managed conservatively. Accurate, non-invasive differentiation between rBM and RN is critical
for effective patient care but remains an unmet clinical need.
This project aims to investigate the use of advanced dual-nuclei MRI techniques, proton-based diffusion-
relaxation correlation spectrum imaging (DR-CSI) and sodium imaging, to non-invasively differentiate between
rBM and RN and to monitor microstructural changes in BM patients undergoing SRS. DR-CSI enables sub-voxel
characterization of tissue microstructure by quantifying components with different diffusion and T2 relaxation
properties, while sodium imaging measures total sodium concentration (TSC), which increases with cell death
and changes in membrane permeability, providing complementary information to proton-based MRI.
Aim 1 will develop and validate DR-CSI and sodium imaging biomarkers in BM patients with radiographic
progression scheduled for surgical resection or biopsy. Pre-operative imaging will be acquired to identify biopsy
targets with distinct microstructural features. We will obtain stereotactic image-guided biopsies from these
regions and determine pathological diagnosis of rBM or RN. We will use statistical models, including logistic
regression and ROC analysis, to assess the predictive value of imaging biomarkers to differentiate between rBM
and RN, validated against histopathological diagnosis. Aim 2 will investigate longitudinal microstructural changes
following SRS in BM patients. Dual-nuclei MRI will be performed at baseline (pre-SRS) and at 2 weeks, 3 months,
and 6 months post-SRS. We hypothesize that early changes in DR-CSI and sodium imaging at 2 weeks and 3
months will predict treatment response at 6 months, as determined lesion-by-lesion using the RANO-BM criteria.
Successful completion of this project will establish advanced dual-nuclei MRI techniques as non-invasive
imaging biomarkers for differentiating rBM from RN and for monitoring treatment response in BM patients. This
advancement has the potential to significantly impact clinical practice by improving diagnostic accuracy, guiding
patient management, reducing unnecessary invasive procedures, and enabling timely interventions. Moreover,
these imaging approaches may have broader applications in other cancers where distinguishing between
progressive disease and treatment effects is crucial.

Public health relevance
PROJECT NARRATIVE Brain metastases are common and challenging brain tumors that can recur after radiation treatment or develop radiation-induced necrosis, both of which look similar on standard MRI but require different treatments. This project seeks to develop advanced MRI techniques to non-invasively differentiate between recurrent tumors and radiation-induced tissue damage in patients with brain metastases. By improving diagnostic accuracy, this research aims to guide appropriate patient care, reduce unnecessary procedures, and ultimately improve outcomes for individuals affected by brain metastases.